Beneficial microbe driven rewiring of metabolic pathways in the gut and liver

SUMMARY
Gut microbes generate a wealth of bioactive small molecules that are absorbed by the body and impact a
plethora of physiological processes. Indeed, it is estimated that about 10% of all metabolites in circulation are
derived from gut microbes. Despite the clear significance of gut microbe generated metabolites towards health,
relatively little is known about how these metabolites mechanistically influence aspects of host biology. This is
important because quantitative and qualitative abnormalities of the microbiota, and microbiota generated
metabolites have been associated with metabolic conditions such as adult-onset diabetes, metabolic syndrome,
nonalcoholic steatohepatitis, and obesity. With the goal of developing novel live biotherapeutics (beneficial
microbes) to treat these metabolic conditions, our research group published that supplementation of mice fed a
high fat and high sugar diet (western-style diet) with a novel beneficial microbe, namely Lactococcus lactis subsp.
cremoris (LLC) lowers total cholesterol, decreases hepatic adiposity, and lowers the levels of pro-inflammatory
cytokines in the liver. The goal of my graduate school studies, and the focus of this F30 proposal is to characterize
the metabolome of western-style diet fed and LLC supplemented mice in an attempt to identify LLC-generated
small molecules that confer its beneficial effects on the host. To this end, employing mass spectrometry-based
metabolomics for analysis of small molecules, I generated preliminary data that demonstrate salient differences
in the metabolite composition of western style diet fed mice supplemented with LLC compared to saline control.
Computational analysis of the metabolomics dataset for pathway enrichment associated with the metabolomic
profile using Mummichog v2.0 software revealed that LLC supplemented mice had metabolomic features
associated with increased lipid and fatty acid metabolism, with Cytochrome P450 (CYP450) activity that functions
in xenobiotic elimination in the liver, and with the activation of the Nrf2 cytoprotective signaling pathway. Based
on my preliminary data, I hypothesize that metabolites generated by LLC act as regulatory integrators of host
metabolism, especially in the context of a western style diet. Furthermore, I hypothesize that metabolites
generated by LLC confer cytoprotective influences in the liver of mice by enhancing CYP450 activity, and by
activating cytoprotective Nrf2 signaling pathway. I will test the hypothesis by 1) identifying LLC-induced shifts in
the metabolome of mice fed a western style diet in the gut, liver, and hepatic portal vein of gnotobiotic and
specific pathogen free mice and by 2) identifying the therapeutic target of LLC-mediated cytoprotection in the
liver using clinically relevant mouse hepatic injury models. Our findings may uncover novel bacterial-generated
bioactive metabolites that may be used as the next-generation therapies for disease of the liver. Through this
research plan, I will be trained in gnotobiotic mouse husbandry, metabolomics analysis, mouse liver injury
models, and histological analysis of liver tissue, all of which will form a basis to my career goal of becoming a
gastroenterologist and physician scientist focusing on diseases of the liver.

Public health relevance
PROJECT NARRATIVE Recent years have seen the development of the concept that gut microbes provide a wealth of bioactive small molecules toward the host, and that these small molecules can consequentially influence diverse physiological processes. Our research group demonstrated that supplementation of mice fed a high fat and high sugar diet (Western-style diet) with a novel beneficial microbe, namely Lactococcus lactis subsp. cremoris (LLC) lowers total cholesterol, decreases hepatic adiposity, and lowers the levels of pro-inflammatory cytokines in the liver, but the mechanisms whereby this beneficial effect occur is unknown. We will identify LLC-induced shifts in the metabolome of mice fed a Western style diet and identify the therapeutic targets of LLC mediated cytoprotection in the liver.